Landscape fire smoke and birth outcomes in Sub Saharan Africa

Summary
Landscape fire smoke and birth outcomes in sub-Saharan Africa
Understanding the effect of landscape fire smoke on pregnancy and child morbidity and
mortality in sub-Saharan Africa is needed because this is the region most affected by
landscape fires, accounting for 70% of the total burned area worldwide. Most fires are
agricultural fires (41% of 70% of the burned area), which is distinct from high-income
countries. A recent meta-analysis provided suggestive evidence for an increased risk of
birthweight reduction, low birthweight, and preterm birth in relation to wildfire smoke during
pregnancy. However, the results were inconclusive due to the large heterogeneity in
methods across studies. Available evidence is dominated by studies from the United States
and Brazil. This project is submitted as a 1 year supplement and provides synergies with the
CHaracterizing Effects of Air Quality In Maternal, Newborn and Child Health (CHEAQI-
MNCH) Research Project. The supplement will enhance and expand upon the CHEAQI
aims. CHEAQI, covers air pollution but not specifically landscape fire smoke. We
hypothesize that landscape fire smoke is positively associated with adverse birth outcomes
independent of ambient PM2.5. More specifically the project aims to quantify the association
between landscape fire smoke and birth outcomes in selected cohorts within the HE2AT
centre, a DSI Africa Research Hub. In addition, the project will develop a federated data
infrastructure to include landscape fire smoke in the CHEAQI database, making it easily
accessible for this and future analyses.

Public health relevance
Narrative Landscape fire smoke and birth outcomes in sub-Saharan Africa Africa is the continent that experiences the most landscape fires in the world. There is emerging evidence that if pregnant women are exposed to smoke from these fires, their babies are likely to be born smaller than normal, or earlier than usual. However, most of this evidence has been generated from studies done in the USA and in Brazil. This proposed research will test these assumption in sub-Saharan Africa. We will make use of data on the birth outcomes from some of the data that is being assembled as part of the NIH funded HE2AT center. The project will leverage and complement the CHEAQI-MNCH project that is asking similar question on other pollution exposures and their effect on the pregnancy outcomes for mothers and their babies.